Administrative Core

The Oklahoma Rheumatic Disease Research Cores Center (ORDRCC) facilitates, supports, and grows
collaborative rheumatic disease research through fostering junior rheumatic disease investigator career
development, forging national collaborations, making available cutting-edge technologies, and providing well-
phenotyped clinical data and biospecimens to understand the pathogenesis, prediction, prevention, and
precision treatment of rheumatic diseases. These goals are being met and have resulted in the successful
launch of at least 33 new rheumatic disease investigator careers (local and distant), new or renewed
collaborative, multi-investigator NIH rheumatic disease research grants, increasing collaborations, novel NIH-
funded and investigator-initiated clinical trials with partnered mechanistic studies, and enhanced diversity in
rheumatic disease research and researchers. The ORDRCC includes individuals from numerous scientific and
clinical disciplines, spanning 26 current center investigators, 22 junior center investigators (12 local, 10 distant)
and 12 nominated Scholars. The Administrative Core serves as the ORDRCC centralized governing resource
and a liaison between the ORDRCC leadership, the Research Cores, all Center Investigators, and the
Advisory Committee. The main purpose of Admin Core is to develop new rheumatic disease investigators
through local and distant Junior Center Investigator and Scholars programs which expand use of our patient
collections and clinical data, as well as access to advanced technologies. We propose a new structured
pipeline program to provide early exposure to rheumatic disease patients and investigation to trainees
spanning from undergraduates to housestaff. We will also augment a multi-faceted Enrichment Program with
weekly seminars and an annual all-day symposium with new web-enabled workshops for professional
development, a new Scientific Writing Success Center, and an expanded formalized mentor-development
program. The Administrative Core also serves as the primary communication hub for the ORDRCC. Based
upon input from our patient advisors, we propose to expand communication with our patients and their
advocates, as well as broaden communication to our new external partners, outside JCIs/Scholars and the
broader scientific community. The ORDRCC will expand Core and Collection use and outreach through
collaborations with other Center awards. Finally, the Administrative Core will provide oversight, management,
and prioritization of resources, ensure regulatory compliance, and grant management oversight and serve as
the nidus for interactions with the Advisory Committee which is inclusive of Internal and External members to
ensure suggestions are vetted and implemented. This Core will also provide the overall Leadership and
oversight for the Center. The ORDRCC will use annual evaluations and assessments, both qualitative and
quantitative, to ensure the Center is meeting goals and to help prioritize resources, assess effectiveness, and
refine the program as necessary to ensure the needs of our patients, participants and investigators are met.